The Role of fs-ps Dynamics in Enzymatic H-Transfer

DESCRIPTION (provided by applicant): One of the holy grails in contemporary enzymology is to identify and characterize enzyme motions at the femtosecond time scale and their relationship to the reorganization and distance sampling motions that determine the rate of the chemical step. The objective of this application is to characterize the enzyme active site dynamics at the femtosecond to picosecond time scale (using 2D IR vibrational spectroscopy) and relate them to the catalyzed H-transfer reaction (using temperature dependence of the intrinsic kinetic isotope effects - KIEs). The central hypothesis is that the spectroscopically measured enzyme dynamic motions and the temperature dependence of KIEs can be correlated within the framework of the Marcus-like models, yielding a unified model that relates the enzyme's dynamics and functionality. We plan to test our central hypothesis and accomplish the objective of this application using the enzyme formate dehydrogenase (FDH) as a model system by pursuing the following three specific aims: 1) Establish the dynamic signatures of an optimized tunneling-ready configuration. The working hypothesis for this aim is that our recent discoveries that the active- site dynamics of FDH in a transition-state-analog complex are unusually rigid and its intrinsic KIEs are temperature independent reflect the formation of a well organized, tunneling-ready configuration. We will test this hypothesis by measuring the temperature dependence of the intrinsic KIEs and the frequency- frequency time correlation function (FFCF) for the antisymmetric stretch of the azide anion in transition state analog complexes of site-specific mutants of FDH. 2) Characterize the time scales for active-site motions that reflect donor-acceptor distance sampling. The working hypothesis is that the promoting vibrations that have been invoked in connection with temperature dependent KIEs occur on the time scale of hundreds of femtoseconds. We will test this hypothesis by measuring the temperature dependence of the enzyme dynamics using 2D IR spectroscopy and correlating that temperature dependence with that of the intrinsic KIEs. 3) Determine whether the active site dynamics of FDH are localized or collective. Our working hypothesis is that the dynamic motions of the enzyme that contribute to donor acceptor distance sampling are collective motions of the active site. We will test this hypothesis by measuring the dynamics of the active site using a second vibrational chromophore, azo-NAD+, in the ternary complex of FDH with azide to compare the dynamics measured at this second location with those for the azide. The proposed research will identify the relationships between the various components of the active site dynamics at the femtosecond to picosecond time scale and the intrinsic KIEs measured with the azo-NAD+. These outcomes are expected to have significant overall impact because identifying the relationship between active-site dynamics and the kinetic properties of the catalyzed reaction will allow us to exploit this relationship to address the controversy surrounding the role of such dynamics in enzyme catalyzed H-transfer reactions.

Public health relevance
PUBLIC HEALTH RELEVANCE: There is the promise that the insights gained from this research will clarify the influence of enzyme motions on the chemical step contributing to a comprehensive theory of enzyme-catalyzed reactions. The outcomes of this research will enable efforts to incorporate an understanding of the role of enzyme motions in structure-based rational drug design efforts improving the potential for success in developing new pharmaceuticals to treat an array of diseases. There is the promise that the insights gained from this research will clarify the influence of enzyme motions on the chemical step contributing to a comprehensive theory of enzyme-catalyzed reactions. The outcomes of this research will enable efforts to incorporate an understanding of the role of enzyme motions in structure-based rational drug design efforts improving the potential for success in developing new pharmaceuticals to treat an array of diseases. __SpecificAimsTextDelimiter__ A. Specific Aims Enzymes are involved in a wide range of human diseases and are the targets of nearly half of pharmaceuticals currently in use. A molecular understanding of how enzymes interact with substrates on their way to products is the foundation for rational drug design. There is an emerging, view that specific enzyme motions (denoted here as dynamics) play a role in enzyme-catalyzed reactions, but the details of this idea are a source of significant controversy. A general theoretical framework, often referred to as a Marcus-like model, for interpreting the results of reaction rates and kinetic isotope effects (KIEs) has emerged. This model suggests that femtosecond to picosecond motions of the enzyme are likely to be important in many of these reactions. Computational studies of several enzymatic systems support this conclusion. Nevertheless, there are no direct experimental measurements of enzyme dynamics at the femtosecond time scale that link such motions to the Marcus-like model. Although characterizing enzyme dynamics at this time scale is challenging, recently developed two- dimensional infrared and vibrational echo spectroscopies can measure active-site fluctuations at this time scale. There is a critical need to characterize enzyme active-site motions at the femtosecond time scale and their relationship to the reorganization and distance sampling motions that determine the rate of the chemical step. Our long-term goal is to understand how protein dynamics influence enzyme-catalyzed reactions so that they can be exploited in rational drug design efforts. The objective of this application, which is the next step in pursuit of the long-term goal, is to characterize the enzyme active site dynamics at the femtosecond to picosecond time scale in NAD(P)-dependent enzymes and relate them to the reorganization and distance sampling motions that determine their kinetic properties. The central hypothesis is that the spectroscopically measured enzyme dynamic motions and the temperature dependence of KIEs can be interpreted within the framework of the Marcus-like models, yielding a unified model that relates the enzyme's dynamics and functionality. We have formulated this hypothesis on the basis of strong preliminary data from our laboratory showing that the active site of transition-state-analog complexes of formate dehydrogenase (FDH), in contrast to both the binary complex and most other proteins, is rigid on time scales longer than a few picoseconds but show significant sub- picosecond dynamics. We have also shown that FDH exhibits an inflated and temperature- independent kinetic isotope effect indicative of hydrogen tunneling and a tunneling-ready configuration with an optimal donor acceptor distance. These results are consistent with the Marcus-like model and with computational studies. The rationale for this work is that, once it is known how the active-site dynamics of enzymes correlate KIE measurements, we can then understand the role of those dynamics in enzyme-catalyzed reactions addressing the persistent controversy in this field and providing a foundation for drug-design efforts that account for such enzyme motions. In addition to our supportive preliminary data, we are particularly well prepared to undertake the proposed research because the research team brings together expertise in two-dimensional infrared spectroscopy and intrinsic KIE studies of enzyme catalyzed reactions, allowing us to employ these approaches on the exact same enzymatic systems, a critical feature contributing to the potential success of the proposed study. We plan to test our central hypothesis and accomplish the objective of this application by pursuing the following three specific aims: 1. Establish the dynamic signatures of an optimized tunneling-ready configuration. Based on work that will be presented under Preliminary Studies, the working hypothesis for this aim is that the absence of active-site dynamics at a time scale of 10 ps or longer in a transition-state- analog complex reflects the formation of a well organized, tunneling-ready configuration. 2. Characterize the time scales for active-site motions that reflect donor-acceptor distance sampling. Our working hypothesis is that the protein promoting vibrations that have been invoked in connection with temperature dependent KIEs modulate the DAD on the time scale of hundreds of femtoseconds. 3. Determine whether the active site dynamics of FDH are localized or collective. Our working hypothesis is that the dynamic motions of the enzyme that contribute to DAD sampling are collective motions of the active site. The proposed research is innovative in that previous experimental studies have focused either on the kinetics or the direct spectroscopic probes of protein dynamics and the two approaches have not been applied to the same enzymatic system. This work is, therefore, a unique effort to combine these two complimentary approaches making it possible to determine the relationship between the insights they each provide. This innovative combination is projected to yield the following expected outcomes: The work proposed in aims 1 and 2 will identify the relationships between the various components of the active site dynamics at the femtosecond to picosecond time scale and the kinetic behaviors that have been interpreted in terms of such motions in the model system, FDH. The proposed work in aim 3 will examine whether these motions are localized in a few atoms close to the reactive functionality, or are collective motions of the active site. FDH is a good model system and the labeled cofactors to be developed for these studies can, in principle be used to study other NAD(P)-dependent enzymes. These outcomes are expected to have significant overall impact because identifying the relationship between active-site dynamics and the kinetic properties of the catalyzed reaction is one of the holy grails in the study of contemporary enzyme catalyzed H-transfer reactions and enzymology in general.